Complement Resistance Acquired During Acute to Persistent Rubulavirus Infection

For many RNA virus infections, an initial acute infection can transition to a prolonged or persistent
infection, in which infected cells survive and continue to produce progeny virus. Complement (C’) is a
powerful innate immune system which can directly lyse virus-infected cells or neutralize virus (1-4), but
the role of C’ in controlling persistent respiratory RNA virus infections is not well understood. Given that
viruses have mechanisms to block C’-mediated cell lysis, persistent infections can set up a prolonged
inflammation cycle – where activated C’ continues to provide damaging inflammation, but viral inhibitory
mechanisms block elimination of pathogen and infected cells.
This project emerged from our striking findings that during an initial acute infection of human lung
cells with the Rubulavirus Parainfluenza virus 5 (PIV5), infected cells are very sensitive to C’-mediated
lysis. Importantly however, after transitioning to a persistent infection, PIV5-infected cells are nearly
completely resistant to C’ lysis. Our transcriptomics data show that PIV5 acutely infected cells have low
level expression of C’ inhibitors, but this shifts to high level expression of cellular C’ inhibitors Factor H,
Factor I, Vitronectin and Clusterin in persistently infected cells.
Our central hypothesis is that PIV5 persistently infected cells acquire resistance to C’-mediated
lysis due to their acquired ability to express high levels of C’ inhibitors Factor H and Vitronectin. Our
goals are to identify: 1) the mechanisms for acquiring C’ resistance during the PIV5 acute-to-persistent
transition (Aim 1), and 2) consequences of this shift for production of C’-resistant virus (Aim 2).
Aim 1 will define the mechanism for differential sensitivity of airway cells to C’-mediated lysis
during transition from acute to persistent infection. Engineered respiratory tract cell lines and primary
tracheal or bronchial air-liquid interface (ALI) cell cultures will be used to test the hypothesis that
synthesis of C’ inhibitors Factor H and Vitronectin by persistently infected cells results in conditioning of
the cells to be resistant to C’-mediated lysis. Aim 2 will identify C’ factors associated with virus particles
derived from acute versus persistently infected cells and define the sensitivity of persistent virus to C’-
mediated neutralization. Proteomics and biochemical assays will test the hypothesis that virus derived
from persistently infected cells will be C’-resistant due to recruitment of Factor H or Vitronectin.
Results from our work on C’ interactions with persistent RNA virus infections will have strong
potential to inform therapeutics, given: 1) the clinical impact of prolonged viral respiratory infections, 2)
polymorphisms in C’ genes can correlate with severity of viral infections, and 3) clinical trials for
respiratory tract infections are underway with drugs that modulate C’ responses.

Public health relevance
There is intense interest in identifying innate immune mechanisms, such as Complement, that are involved in controlling viruses, particularly those which establish persistent or prolonged infections. Our work on C’ resistance during persistent infections will have strong potential to inform future therapeutics, given: 1) the long-standing clinical impact of prolonged respiratory infections, 2) that polymorphisms in C’ genes can correlate with severity of viral infections (39, 42) and 3) that new clinical trials are underway with drugs that modulate C’ responses. .